Clinical factors in aminoglycoside-induced ototoxicity

SUMMARY
Congenital and acquired hearing loss during infancy has lifelong, debilitating consequences. Early
identification of hearing loss improves the efficacy of auditory (re)habilitation, communication outcomes and
quality of life for these individuals. Systemic infections are a major cause of morbidity and mortality in neonates
admitted to the neonatal intensive care unit (NICU). Bacterial infections (i.e., sepsis) are treated empirically with
antibiotics, including the life-saving aminoglycosides, like gentamicin. In preclinical models, aminoglycoside
treatment induces dose-dependent and frequency-selective sensorineural hearing and balance deficits (i.e.,
ototoxicity), as well as acute kidney damage. Systemic inflammation induced by bacterial ligands potentiates
this drug-induced hearing loss. Infants with (suspected) sepsis require urgent gentamicin treatment, and appear
to have a greater risk of hearing loss in pilot studies. Our long-term goal is to reduce the incidence, and extent,
of drug-induced hearing loss among infants discharged from the NICU (graduates). We propose a non-
interventional translational study of this vulnerable population to:
Aim 1: Identify if gentamicin dose-dependently increases hearing loss in infants
There is little rigorous data showing the dose-dependency and frequency-selectivity of aminoglycoside-
induced hearing loss in humans. We will test the hypothesis that greater cumulative gentamicin dosing increases
the degree of hearing loss in NICU graduates.
Aim 2: Verify if (suspected) sepsis potentiates gentamicin-induced hearing loss in infants
Pilot data suggest that NICU subjects with (suspected) sepsis and ≥5 days of gentamicin therapy have a
greater risk of hearing loss compared to their age-matched peers. We will verify these pilot data by testing the
hypothesis that (suspected) sepsis increases the risk, and extent, of gentamicin-induced hearing loss in NICU
graduates.
If gentamicin-induced hearing loss in NICU graduates is (i) dose-dependent, and/or (ii) potentiated by
(suspected) sepsis, these data will predicate the need for ototoxicity monitoring prior to, and following, discharge
from the NICU. If implemented, this will (i) ensure earlier detection of hearing loss, (ii) improve the efficacy of
auditory (re)habilitation strategies. In addition, identifying the incidence and dose-dependency of gentamicin-
induced hearing loss will facilitate subsequent studies to determine if (i) reducing ototoxic aminoglycoside dosing,
and/or (ii) alternative antibiotic or otoprotective strategies, better preserve lifelong hearing in humans. These
strategies will enable NICU graduates to better meet their peers’ listening and spoken language skills to fulfill
their educational potential and lifelong contributions to society.

Public health relevance
NARRATIVE Systemic inflammation induced by bacterial ligands potentiates aminoglycoside-induced hearing loss in preclinical models. We hypothesize that: (i) higher frequency audiometric testing (than currently used) will show dose-dependent aminoglycoside-induced hearing loss; and (ii) (suspected) sepsis potentiates the risk of aminoglycoside-induced hearing loss in infants discharged from the neonatal intensive care unit (NICU). If study data support these hypotheses, these outcomes will predicate the need for ototoxicity monitoring of infants prior to, and following, discharge from the NICU, and developing alternative antibiotic dosing strategies.